Profiling and leveraging bystander T cells within the tumor microenvironment

PROJECT SUMMARY/ABSTRACT Per the FOA, this section is not required. There is no change by the supplemental activities from the parent award.

Public health relevance
PROJECT NARRATIVE Per the FOA, this section is not required. There is no change by the supplemental activities from the parent award.